Targeting ABL kinases to regulate epithelial cell plasticity and regeneration following injury

ABSTRACT
Tyrosine phosphorylation networks have been implicated in the regulation of epithelial cell plasticity, which is
often induced by injury in multiple tissue types. Regeneration following injury is mediated by dynamic
intercellular signaling among diverse epithelial progenitor cell populations and residual cells. Recent studies
have revealed a significant role for cell plasticity mechanisms induced by injury where cells from one region
contribute to repair of another region after severe and acute damage. Despite the identification of multiple
region-specific progenitor cells activated following injury, the identity of molecules that might be therapeutically
targeted in response to injury to promote activation of progenitor cell types has remained elusive. We recently
showed that Abl kinases are highly activated in bronchial epithelial cells in response to pathogen-induced injury,
and that Abl inactivation in a subpopulation of airway cells promotes intercellular signaling among lung epithelial
cell progenitors to induce alveolar regeneration after bacterial pneumonia challenge. Further, we have recently
found that inhibition of Abl kinases after airway damage induced by toxic agents (SO2 exposure) promotes
basal cell proliferation and enhances differentiation. Together these data reveal for the first time a role for Abl
kinases in regeneration of both the alveolar and airway epithelium after injury by pathogens and toxic agents.
The overall hypothesis is that activation of the Abl kinases in response to injury promotes lung epithelial
damage, and that Abl inactivation in lung epithelial progenitors promotes efficient and rapid regeneration and
re-establishment of tissue architecture following injury. The specific aims are: 1. Evaluate the role of Abl kinases
in the regulation of alveolar epithelium regeneration in response to pathogen-induced injury. To this end we
will: A) evaluate the role of Abl kinases in alveolar regeneration in response to acute lung injury and assess
the effectiveness of Abl inhibitors to enhance both residual progenitor cell proliferation as well as invoking
plasticity of airway progenitors for efficient and rapid alveolar regeneration; and B) assess whether Abl1 targets
the HIF1 transcription factor in response to alveolar injury and repair. 2. Define the Abl-dependent pathways
implicated in airway epithelium regeneration. In this aim, we will A) evaluate whether Abl kinases modulate the
response of the airway epithelium during injury and whether Abl inactivation functions to promote airway
regeneration required to restore airway epithelial architecture and function; and B) identify Abl-regulated
pathways altered in the regenerating airway epithelium and evaluate the role of selected Abl targets including
Yap1 in the regulation of airway epithelial cell proliferation, differentiation, and survival after injury. These
studies break new ground as they will define novel Abl-regulated pathways activated in response to injury and
identify epithelial progenitors with enhanced cell plasticity in response to Abl inactivation, leading to
regeneration of the lung epithelium.

Public health relevance
PROJECT NARRATIVE Epithelial cell plasticity is often induced by injury in multiple tissue types. Regeneration following injury requires dynamic intercellular signaling among epithelial progenitor cell populations and surrounding niches. These studies will define novel Abl-regulated pathways activated in response to injury and identify epithelial progenitors with enhanced cell plasticity in response to Abl kinase inactivation leading to regeneration.